Tracking the dynamic trajectory of behavioral, physiological, and neurobiological stress responses in female adolescents at high and low familial risk for depression.

Project Summary/Abstract. Stress and a parental history of Major Depressive Disorder (MDD) are among the
most potent risk factors for future MDD development. Evidence suggests that the offspring of parents with
MDD are especially vulnerable to the development of maladaptive responses to stress. Early adolescence is a
critical window for studying MDD risk, as this developmental stage is just prior to the peak period of initial MDD
onsets and a time of enhanced stress sensitivity, especially among females. Despite the importance of stress
in MDD onset, the neural mechanisms underlying stress responses in female adolescents at high familial risk
for MDD remain unclear. Furthermore, little is known about how stress-induced brain network changes may be
linked to physiological and behavioral responses to stress and be predictive of future MDD onset. In this R01
resubmission, we aim to test a model in which having a parental history of MDD increases the risk for
dysfunctional dynamic default mode network (DMN) – Central Executive Network (CEN) stress responses, two
networks consistently linked to MDD pathophysiology and stress responsivity, prior to the onset of depression.
Specifically, we expect that adolescents with versus without a parental MDD history will spend more time and
persist longer in a DMN-CEN co-activated pattern in response to stress. We further hypothesize that this
maladaptive DMN-CEN pattern will predict maladaptive psychophysiological and behavioral responses seen in
the adolescents’ natural environment. Together, we expect that this stress sensitive profile of dysfunctional
dynamic DMN-CEN, psychophysiological, and behavioral responses will predict future depression onset. We
focus on DMN-CEN dynamics given accumulating evidence showing that, relative to static network properties,
brain network dynamic properties may be more robustly associated with MDD pathophysiology as well as the
behavioral and psychophysiological processes impacted by stress and MDD. In the PI’s own published work,
adults with MDD as well as healthy adolescents with a maternal history of MDD spent more time and persisted
longer in a DMN-CEN co-activated pattern relative to healthy controls and adolescents without a parental MDD
history, respectively. Moreover, longer DMN-CEN persistence prospectively predicted greater perceived stress
among the high-risk adolescents. This suggests that dynamic DMN-CEN properties may be a critical premorbid
MDD vulnerability marker that could aid in the identification of adolescents vulnerable to future MDD onset.
Building on an extensive set of preliminary data, we will investigate changes in DMN-CEN dynamic properties
from before and after an acute psychosocial stressor, along with changes in heart rate (HR), heart rate
variability (HRV), skin conductance (SC), and cortisol output in a sample of 148 13–15-year-old unaffected
females with (n = 74) and without (n = 74) a parental history of MDD. Wearable and smartphone technology
will be used to track daily stress vulnerability markers (HR, HRV, SC, sleep disturbances, perceived stress,
stress-reactive rumination) every 6 months during an 18-month follow-up.

Public health relevance
Project Narrative The offspring of parents with Major Depressive Disorder (MDD) are highly vulnerable to the negative effects of stress, especially among adolescent females, including the development of maladaptive behavioral, physiological, and hormonal responses to stress. Yet the functional brain network dynamics underlying aberrant stress responses in vulnerable female adolescents at risk for MDD remain unclear and little is known about how stress-induced brain network changes may be linked to physiological and behavioral stress responses and may be predictive of future MDD onset. This R01 resubmission will fill these knowledge gaps by combining a well- established laboratory psychosocial stress paradigm with intensive longitudinal tracking of depressive symptomology as well as behavioral and physiological responses to “real world” stress using smartphone and smartwatch technology, with the work leading to novel insights about potential stress-related MDD biomarkers, which may aid in earlier identification of vulnerable adolescents.